Assessment of Mast Cell Degranulation in Infarcted Myocardium Using Quantitative Multiparametric MRI

PROJECT SUMMARY
The overall objective of the proposed project is to evaluate the effectiveness of a novel pharmacological
treatment of myocardial infarction (MI) using quantitative multiparametric magnetic resonance imaging (qMRI).
MI is a major cause of death and disability worldwide. Urgent reperfusion of the occluded artery to restore
myocardial blood flow is central to the clinical management of acute thrombotic MI (AMI). However,
recanalization of the culprit artery may also result in unintended injury by causing microvascular obstruction
(MVO), intramyocardial hemorrhage (IMH), and edema during the acute phase. In the setting of chronic MI, iron
deposition and fat accumulation (lipomatous metaplasia, LM) are frequently observed in infarcted myocardium.
All these biomarkers are strong predictors of major adverse cardiovascular events such as heart failure. To date,
however, there have been no effective therapeutic strategies for attenuating either MVO, IMH, chronic iron
deposition, or LM post-reperfusion. Mast cells (MC) are derived from blood-borne, multipotent hematopoietic
progenitor cells that, once located in tissue, differentiate to a final phenotype under the influence of the local
microenvironment. In general, MC exert their physiological and pathological functions by releasing cytoplasmic
granules (degranulation) containing a variety of biologically active mediators. Recent experimental studies have
shown that hematoma growth, edema expansion and overall neurological damage after cerebral ischemia-
reperfusion can be reduced by early treatment with MC stabilizers, which are known to suppress MC
degranulation. Equally important, atherosclerosis research over the last two decades has provided strong
evidence for MC involvement in foam cell formation and plaque development. Based on these studies, we
hypothesized that MC stabilization via the administration of over-the-counter anti-allergy medication loratadine
reduces myocardial edema, IMH volume and improves myocardial microcirculation in the acute MI setting; and
attenuates LM of infarcted myocardium in the chronic phase. Quantitative cardiovascular MR (qCMR) imaging
has been widely used to characterize myocardial ischemia, hemorrhage, edema, inflammation, iron deposition,
fat accumulation and other pathological conditions. In this proposal, we aim to validate the effectiveness of MC
stabilizer loratadine on structural and functional cardiac remodeling post-pharmacotherapy in a porcine model of
MI by temporally following imaging biomarkers of acute and chronic MI using well-established qCMR techniques.
Successful completion of the project will provide initial validation that early loratadine intervention has the
potential to be a novel therapeutic strategy for prevention of heart failure post-MI as evaluated by our quantitative
multiparametric MRI approach.

Public health relevance
PROJECT NARRATIVE To date, there are no effective treatments for improving blood flow and preventing fat deposition in the injured heart muscle after a heart attack, despite tremendous research efforts in the field. Our goal is to use a novel noninvasive imaging method that will provide reproducible and accurate assessment of the blood flow and fat accumulation within injured muscle after treatment with antiallergic medications.